Arrhythmia Mechanisms Modulated by Intercalated Disc Extracellular Nanodomains

PROJECT SUMMARY
Loss-of-function mutations in the genes encoding the cardiac isoform of the voltage-gated sodium channel
(Nav1.5) have been associated with the Brugada Syndrome (BrS), and loss-of-function of plakoglobin has been
associated with Arrhythmogenic Cardiomyopathy (ACM). Both diseases are associated with inconsistent
experimental findings, can be revealed by basic experimental differences, often affect the right ventricle, are
associated with intercalated disc proteinopathies, and for both, there are few treatments to prevent arrhythmias.
We have previously demonstrated that another loss-of-function in the intercalated disc protein connexin43 can
be concealed by choice of experimental perfusate, potentially explaining why disease-related conduction slowing
can be measured in some laboratories but can remain concealed in an intact organism with “normal” electrolyte
composition. We also previously demonstrated that induced acute interstitial edema (AIE) is greater in the right
relative to the left ventricle. Since AIE can unmask gap junction uncoupling, we hypothesize that AIE can unmask
two other intercalated disc diseases: BrS and ACM. Finally, if AIE can unmask intercalated disc diseases, our
data suggest that these diseases may be treatable by managing intercalated disc microdomain separation.
In this project, we propose an innovative hypothesis that the concealed nature of BrS and ACM in intact tissue
is mechanistically tied to a newly discovered form of cell-to-cell communication called ephaptic coupling. Upon
successful completion of these aims, we will produce new methods to unmask these diseases in their pre-
manifest stage, allowing for early detection. Further, the work will suggest important new therapies for two
diseases with few effective therapeutic options and poor patient outcomes.

Public health relevance
PROJECT NARRATIVE The life-threatening diseases Brugada Syndrome and Arrhythmogenic Cardiomyopathy are associated with mutations in proteins with high expression in the intercalated disc: for example, sodium channels and plakoglobin, respectively. Despite that these mutations are thought to be functionally expressed throughout an organism’s lifetime, the disease can be “concealed,” and specifically, patients do not always exhibit a diagnostic ECG, which suggests that mechanisms for treating the disease are in fact tied to the mechanisms that conceal the disease. We hypothesize that a form of cell-to-cell coupling, called ephaptic coupling, can conceal the disease independent of sodium channel or structural protein remodeling, and promoting ephaptic coupling should reduce the risk of lethal arrhythmias in patients with these disease-causing mutations.